An Epileptic-Network Closed-loop Stimulation Device (enCLS) Designed to Target and Arrest Ictogenesis

PROJECT SUMMARY
Epilepsy, occurring in 1 percent of the world’s population, is associated with disability, injury, cognitive and
neurological dysfunction, depression, loss of productivity, socioeconomic decline and even death. Of this
population, 30 percent of epilepsy cases are medically intractable, leaving surgical interventions as the only
option for treatment. Whereas open resection, the current surgical standard of treatment, can yield seizure
freedom rates as high as 60-80 percent, these are often associated with cognitive dysfunction and focal
neurological deficits. Particularly, patients with dominant hemisphere mesial temporal lobe epilepsy (MTLE), the
target population for this proposal, are at risk for significant decline in memory and associated disability. It was
estimated that there are nearly 200,000 patients with drug-resistant MTLE waiting for treatment. The only option
for these patients at present is electrical neuromodulation, which, although effective at reducing seizures, only
achieves seizure freedom in ~10% of patients. Patients and their caregivers, however, generally need a 100%
decrease in seizures to safely drive a vehicle, hold down a job, enroll in education programs, or live
independently. This represents a sizeable treatment gap. To answer this unmet need, we identified gaps in the
technology implemented in the current responsive neurostimulation (RNS) device that we aim to address with
this proposal. One, the intended design of RNS is to terminate seizures in response to seizure onset, similar to
a cardiac pacemaker, which senses and responds to maintain regular cardiac rhythm. In practice, however, RNS
does not function this way. Patients with MTLE, on average, have approximately 8 seizures a month. RNS,
however, deploys more than 1000 stimulations a day. Two, the FDA-approved use of RNS is to implant the
recording and stimulation electrodes in one or two areas of the seizure onset zone (SOZ). This seizure control
strategy approaches focal epilepsy as a focus-based disorder, which is outdated. In this proposed study, we plan
to design and implement a proof-of-concept epileptic-network closed-loop stimulation (enCLS) device to address
the two technology gaps of RNS. This device will adopt a new set of pattern detectors to improve the specificity
and timing of ictogenesis detection, coupled with a neurostimulation protocol to stop ictogenesis in the larger
epileptic network beyond SOZ. The enCLS device otherwise assumes the same overall physical design,
functional usage, intended users, use environment, operating principles, and the safety limits of the current state-
of-the-art RNS system. We shall construct a proof-of-concept laboratory enCLS prototype and conduct
experiments to inform the design requirements associated with a minimum viable product (MVP) at the end of
the funding period. The efficacy of enCLS in seizure prevention, hence meeting the need for seizure freedom,
will be compared with RNS. We will leverage the multi-institutional research efforts in partnership with the medical
device industry to bring this technology to human use within five years.

Public health relevance
PROJECT NARRATIVE This project supports the development of a new treatment option (enCLS) for patients with drug- resistant mesial temporal lobe epilepsy. This new enCLS implantable device employs new knowledge and technology on how seizures begin to more accurately detect and deliver neurostimulation to the epileptic brain network to prevent seizures before they start.